National Gnotobiotic Rodent Resource Center

Project Summary:
Environmental factors, especially microbiota, modify genetic susceptibility to many chronic diseases. The
NGRRC provides an essential resource for local, regional and national multidisciplinary investigators to explore
the hypothesis that residental bacteria strongly influence physiologic processes in normal hosts and
pathogenic inflammatory, metabolic and neoplastic responses in genetically susceptible hosts. This unit
provides a resource for broadly based NIH-funded investigators to examine physiologic and pathophysiologic
differences in germ-free (GF, sterile) vs. gnotobiotic (selectively colonized) vs. specific pathogen free mice of
different genetic backgrounds, to explore the functional alterations of normal vs. dysbiotic microbiota in murine
models and human diseases, and to define the functional relevance of bacterial genes. The microbiota can be
precisely manipulated by colonizing GF mice with single or multiple resident or pathogenic bacterial, viral or
fungal strains using isogenic wild type or mutated strains. In addition, fecal transplants can be performed from
murine models or human donors. Aims: 1. Provide GF and gnotobiotic WT and mutant mice, their tissues and
cells to NIH-funded investigators. 2. Derive additional GF mouse strains for NIH -funded investigators. 3.
Support pilot studies for new investigators to generate preliminary data for NIH grant applications. 4. Train
personnel to develop murine and zebrafish gnotobiotic facilities in other institutions. 5. Develop and
characterize complex human and murine microbial communities and a library of bacteria strains to facilitate
reproducible results in gnotobiotic studies (Research Component). We provide a unique and essential
resource for a multidisciplinary group of NIH-funded investigators to study physiologic and patho-physiologic
functions of normal and dysbiotic resident bacteria, with particular emphasis on gene/environ-mental
interactions in genetically altered gnotobiotic mice (transgenic, knockout or spontaneously mutated) with
altered physiology and disease phenotypes. In the past 5 years of funding, the NGRRC provided 8279
gnotobiotic mice to 101 investigators in 49 institutions. 68 funded NIH grants (in 12 Institutes) by 51
investigators as well as 63 grants by other funding agencies depend on gnotobiotic mice from the NGRRC.

Public health relevance
Relevance: Altered microbiota composition (dysbiosis) is associated with a number of inflammatory (IBD, NASH, athero- sclerosis), metabolic (diabetes, metabolic syndrome), neoplastic (colon, pancreatic cancer) and behavioral (depression, autism) disorders. However, the functional consequences of these compositional changes and the role of individual bacterial species remain unknown. Selective colonization of gnotobiotic mice with native or genetically engineered bacterial species or defined consortia can determine bacterial function, host/microbial and microbial/microbial interactions.